INFANTILE ESOPHAGITIS--NATURAL HISTORY AND OPTIMAL THERAPY

To determine the optimal diagnostic strategy, and components and duration of therapy of infantile esophagitis. Both retrospective and prospective components. Infants will be randomized to therapy using a 2x2 factorial design using a prokinetic, an acid secretion inhibitor, both, or dual placebo. Patients will undergo repeat esophageal biopsies and reflux questionnaires to evaluate objective and subjective response to therapy and stability of healing.